Impact of Congenital Hyperinsulinism on Trajectories of Neurocognitive Function Across School Age

PROJECT SUMMARY/ABSTRACT
The overall objective of this K23 application is to provide support for the additional training and experience that
the principal investigator, a pediatric endocrinologist and epidemiologist, needs to develop an independent,
patient-oriented research program in hyperinsulinism. Congenital hyperinsulinism (HI) is the most common
cause of persistent hypoglycemia in infants and children. Onset of hypoglycemia in HI overlaps with a critical
period of neurocognitive development that occurs in the first years of life. While children with HI are more likely
to have neurocognitive deficits, little is known about the factors influencing trajectories of neurocognitive
development in affected children. This project will: (1) identify neurocognitive trajectories in children with HI
employing an accelerated longitudinal design, and (2) examine the relationship between timing of
hypoglycemia exposure and neurocognitive outcomes through comparison of two clinical phenotypes of HI with
natural variation in clinical course. To accomplish these aims a comprehensive neurocognitive battery will be
administered at baseline and repeated at 1- and 2-years after baseline, to school-aged children with cured,
focal HI (hypoglycemia exposure limited to early life), diffuse HI (early life and ongoing hypoglycemia
exposure), and age, sex, and socioeconomic status matched healthy controls. The results of this project will fill
critical gaps in knowledge about the impact of hyperinsulinemic hypoglycemia during periods of marked brain
development and carry significant implications for clinical practice. This study may also have broad implications
for other disorders associated with hyperinsulinemic hypoglycemia, including diabetes mellitus. The principal
investigator will take full advantage of the rich scientific environment and outstanding resources afforded by the
Children’s Hospital of Philadelphia and University of Pennsylvania to achieve her research and training goals.
The proposal includes advanced training in longitudinal data analysis and longitudinal neurocognitive outcome
assessment, which will be achieved through a combination of didactic coursework, practical research
experience, and support form an expert, multidisciplinary mentorship and advisory team. The support of this
K23 will enable the principal investigator to launch a successful career as an independent investigator
dedicated to optimizing neurocognitive outcomes for children with hyperinsulinism.

Public health relevance
PROJECT NARRATIVE Congenital hyperinsulinism is the most common cause of persistent low blood sugar in infants and children and is associated with high rates of neurocognitive impairment. This project will examine trajectories of neurocognitive development in school-aged children with congenital hyperinsulinism and will guide future strategies to improve neurocognitive outcomes.